Modeling red blood cell metabolism in health and disease

PROJECT SUMMARY
Understanding the metabolism of human red blood cells (RBCs) is important for improving medicine surrounding
blood transfusion and inborn errors of metabolism. This proposal aims to use computational genome-scale
metabolic models (GEMs) to advance translational applications for blood transfusions and inborn errors of
metabolism. By population, RBCs are the most common cell in the human body, numbering approximately 25
trillion RBCs per person. The main role of the RBC is to carry oxygen using hemoglobin and, with approximately
260 million units of hemoglobin per cell, RBCs are highly evolved to carry oxygen. Mature RBCs lack
mitochondria and organelles so they cannot synthesize new proteins. Hence, they have evolved elaborate
metabolic mechanisms to regulate their physiology and adjust to environmental stressors. One such stressor is
RBC storage in the blood bank, a crucial part of meeting patients' transfusion needs. Another RBC stressor is
inborn errors of metabolism, such as G6PDH deficiency. Studying RBC metabolism sheds light on these medical
treatments and conditions. The first specific aim is to expand the current state-of-the-art human RBC GEM with
data from our lab's most recent proteomics study of ultra-pure human RBCs. This will enable computational
models of the human red blood cell to reflect RBC metabolism more accurately. The second specific aim is to
use the update or current RBC genome-scale metabolic model to identify metabolic profiles linked to RBC failure
(hemolysis) in storage. To this end, we will use the Recipient Epidemiology and Donor Evaluation Study (REDS)
operated by the NIH NHLBI to enhance knowledge of RBC storage and transfusion medicine.

Public health relevance
PROJECT NARRATIVE Understanding the metabolism of human red blood cells (RBCs), the most abundant cell in the body is crucial for improving transfusion medicine and understanding diseases caused by inborn errors of metabolism and storage in the blood bank. Metabolism of cells (RBCs included) can be modeled with genome scale metabolic models (GEMs) that encapsulate metabolism into a computational form. By using and improving the latest RBC- GEMs, we aim to achieve translational objectives for transfusion medicine and treating inborn errors of metabolism.